Translational Research Core - Health Engagement & Action Translational (HEAT)

The Health Engagement & Action Translational (HEAT) Research Core will employ a multi-level systems approach to designing action-oriented, rigorous community engagement, observational and interventional research to promote improved diabetes outcomes in the greater San Francisco Bay Area and the Central Valley. This goal will be accomplished by 1.) Maintaining and deepening a vibrant and collaborative cross- disciplinary research environment, 2.) Supporting junior investigators, 3.) Disseminating findings among the scientific community and with key stakeholders, including the communities most affected by diabetes, and 4.) Providing timely, authoritative and tailored consultation to a range of stakeholders, including investigators, local health system leaders, community-based organizations, and regional public health, social service and social policy entities.